Structure and regulation of lipid metabolism and transport

PROJECT SUMMARY: We are interested in understanding how lipid-metabolizing enzymes and lipid transport
proteins function and are regulated at the molecular and structural level. Previously, we focused on two enzymes
in phosphatidic acid (PA) metabolism: lipin and phospholipase D (PLD). Lipins are PA phosphatases that
dephosphorylate PA to generate diacylglycerol, which is the penultimate step in triglyceride biosynthesis. Lipins
regulate phospholipid and lipoprotein synthesis, fat storage as triglycerides, fatty acid synthesis, and insulin
sensitivity with implications to obesity, diabetes, and cardiovascular disease. PLDs hydrolyze
phosphatidylcholine to produce the lipid second messenger PA in response to extracellular stimuli. Receptor-
mediated activation of PLD regulates vesicular trafficking, cell proliferation, and cell migration, which has
established them as therapeutic targets for cancer. Despite extensive studies on these highly regulated, multi-
domain enzymes, significant gaps remain in our knowledge of their molecular mechanisms of action. During the
past funding period, we determined the first structures of lipin and PLD, identified a new type of membrane-
binding domain in lipins, and provided insight into PLD activation by lipids and protein effectors. These
discoveries provide an excellent foundation for this application, where our main goals include 1) continuing to
understand how PLD is activated by protein effectors and lipids, and 2) examining the molecular mechanisms
regulating lipin PA phosphatase activity and PA substrate specificity. We will also 3) biochemically and
structurally characterize the nuclear envelope protein phosphatase complex CTDNEP1-NEP1R1, which
dephosphorylates lipin to control lipin PA phosphatase activity; and 4) study the structure and function of Nir lipid
transfer proteins, which transfer PA and phosphatidylinositol between membrane contact sites to replenish pools
of plasma membrane phosphoinositides after hydrolysis by PLC. Structural studies will be complemented by an
array of lipid biochemistry and lipid-protein interaction assays that we are well versed in, hydrogen-deuterium
exchange mass spectrometry, and cellular studies in mammalian cells. A network of collaborators who are
leaders in their respective fields supports these studies. We aim to answer several major questions: (1) How
does the structure of lipid-modifying enzymes allow them to recognize their lipid substrates and interact with the
membrane? (2) What role do structurally and/or functionally uncharacterized domains play in the action of these
proteins? (3) How are these enzymes/proteins regulated? Specifically, are they autoinhibited? how do protein
effectors, lipids, ions, and post-translational modifications regulate activity? and what conformational changes
occur during activation? Overall, this work will improve our understanding of biological mechanisms and provide
information on lipid-protein interactions of physiological and pharmacological significance.

Public health relevance
PROJECT NARRATIVE: Alterations in lipid metabolism and transport are linked to the onset and progression of various human diseases including cancer, diabetes, heart disease, and vision disorders. Our studies will contribute to understanding the molecular mechanisms for the action of enzymes and lipid transport proteins implicated in these processes.